Outcomes of uveitic cataract and uveitic glaucoma surgery

Project summary
Uveitis is associated with visual impairment and higher incidence of poor outcomes following
intraocular surgery—such as cataract surgery or glaucoma surgery. Guidelines proposed to
prevent visual impairment and achieve successful surgical outcomes include quiescence of
inflammation for atleast 3 months pre-operatively and stringent inflammation control in the
perioperative period, however there is limited evidence on which to based practice regarding the
real-world outcomes for patients who undergo uveitic cataract surgery and uveitic glaucoma
surgery. The Systemic Immunosuppressive Therapy for Eye Diseases (SITE) Cohort Study is a
rich database of uveitis patients (17,907 distinct patients followed over 169,194 visits) with very
detailed information on inflammatory status, medications received, surgeries and other
outcomes. The database includes over 250 children under the age of 18 who have had uveitic
cataract surgery and over 100 children who underwent uveitic glaucoma surgeries, in a field
with very sparse literature on pediatric uveitic cataracts and pediatric uveitic glaucoma. Patients
who had incisional cataract or glaucoma surgery with at least one visit in the 6 months prior to
surgery and at least two post-operative visits beyond 8 weeks postoperatively are included in
the analysis. The results from this grant could (1) guide clinicians and patients re: the optimal
management of patients in the peri-operative period to achieve best possible visual acuity and
intraocular pressure control, (2) explore the incidence of subsequent intraocular surgeries,
especially among children, which would impact the planning of surgeries and (3) guide the peri-
operative management of patients to prevent intraocular inflammation and subsequently the
best visual outcomes. The question of whether to leave a child aphakic or not and whether a
trabeculectomy or tube shunt is associated with longer term intraocular pressure control, thus
preserving visual function, will have evidence-based guidelines through this analysis.
These objectives are responsive to the Strategic Plan and goals of the National Eye Institute, to
support applied clinical research concerning blinding eye diseases and preservation of sight,
especially the goal “Establish the causes and etiology of uveitis and improve methods for its
diagnosis, treatment, and prevention.”

Public health relevance
Project Narrative Ocular inflammatory diseases are an important cause of blindness and visual disability in the United States; the incidence and predictive factors for remission of disease and the important complications of cataract and glaucoma surgery are not well-characterized. This research will provide robust data on the outcomes following cataract and glaucoma surgery, and will identify modifiable and unmodifiable risk factors, providing valuable guidance to clinicians and patients dealing with uveitis. The proposed objectives are responsive to the Strategic Plan and goals of the National Eye Institute, to support applied clinical research concerning blinding eye diseases and preservation of sight.